Chemical Biology of the Control of Neddylation by DCN1

Abstract
The long-term goal is to generate and use complimentary chemical and biological probes to study the cullin
RING ubiquitin ligases (CRL’s) and understand their activation controlled by the interaction of by the Defective
in Cullin Neddylation 1 (DCN1) and UBE2M proteins. Because the CRL’s ultimately control ubiquitination of many
diverse proteins, thus regulating their stability, intracellular localization, and function, having spatiotemporal
control over DCN-mediated CRL activity has the potential to unravel the mechanism regulating key cellular
signaling networks and driving disease progression. The health relatedness of this project lies in two facts: 1)
DCN1 is an oncoprotein, amplified in squamous cell carcinomas, that drives a highly malignant phenotype, and
2) CRL driven ubiquitination is a validated target in multiple diseases, particularly cancer and immune
dysfunction. Therefore, inhibitors of the DCN1-UB2M interaction that are potent, selective, and bioavailable have
the potential to be developed as antitumor drugs and possibly for other diseases. Ubiquitination is regulated by
a highly complex, dynamic, and redundant network. Inhibitors of DCN1-UB2M will allow direct interrogation of
the function of sub-portions of the network and are likely to unveil fundamental principles of the regulation
ubiquitination. The generation of complementary cellular and mouse genetic models will enable independent
verification of hypotheses. Finally, the DCN1-UBE2M interaction requires N-terminal acetylation of UBE2M, a
common posttranslational modification controlling protein interactions. Therefore, a strategy for targeting N-
terminal acetylation dependent protein interactions could be widely applicable. The research design and
methods for achieving these goals involves the integrated and recursive use of structure-driven, hypothesis-
based medicinal chemistry; in vitro biochemical measures of affinity and inhibitory potency; in vivo measures of
compound efficacy and pharmacodynamic responses; and in vitro and in vivo measures of compound
bioavailability, distribution, metabolism, excretion, and toxicity. The overall goal is to develop new complimentary
chemical and biological tools to understand the regulation of the ubiquitin-like protein NEDD8, and uncover the
specific role of DCN-mediated neddylation in Cullin-RING ligase substrate receptor exchange, growth factor
signaling, and driving tumor progression. Our aims are: Aim 1: Improve the potency and oral exposure of our
current DCN1/2 inhibitors and generate new chemical probes with sufficient potency and selectivity to enable
ourselves and others to study the consequences of inhibiting this E2-E3 interaction in cells and animals. Aim 2.
Investigate how the composition of cellular CUL1 and CUL3 ligases dynamically responds to environmental
perturbations and the importance of DCN1/2 in this process. Aim 3: Use genetic and pharmacological
approaches to study the effects of inhibiting DCN1 activity in animal tumor models.

Public health relevance
Project Narrative Dysregulation of the Cullin-RING ubiquitin Ligases (CRLs), which regulate the stability and interactions of many proteins inside the cell, is associated with a growing number of diseases, including cancer. The goal of this proposal is to develop new complimentary chemical and biological tools to understand the regulation of the CRLs by the ubiquitin-like protein NEDD8. The proposed studies will provide useful tools for understanding key biological processes and may also lay the foundation for the development of novel therapeutics for the treatment of cancer and other diseases.